Osteocytic function in bone brain crosstalk in Alzheimer’s Disease

SUMMARY
Bone fragility and joint disease present major challenges to the skeletal and dental health of the aging population.
However, therapies for bone fragility treat low bone mass, but overlook approximately 50% of fractures that result
from impaired bone quality. Furthermore, individuals with bone fragility and osteoarthritis (OA), diseases that are
the focus of the parent R01, are at increased risk of cognitive decline, Alzheimer’s (AD), and other related
dementias (ADRD). Vice versa – there is documented, but greatly understudied evidence that AD/ADRD patients
exhibit higher risk for osteoarthritis, falls, and fractures. Here, the addition of collaborators to the parent R01,
along with their established AD outcomes and models, enables us to leverage our ongoing studies of age-related
skeletal degeneration to uncover mechanisms responsible for the coincident decline in skeletal and neurological
health in aging. These studies are motivated by parent grant preliminary data of bone from aged mice and from
TbRIIocy-/- and MMP13ocy-/- mouse bone, all of which exhibit suppression of osteocyte perilacunar canalicular
remodeling (PLR), bone quality, and joint homeostasis. RNAseq and functional studies revealed evidence of
mitochondrial dysfunction in each model, a common mechanism in AD. Even more surprising, pathways of AD
and neurodegeneration where highly enriched in bones from both models of osteocyte-intrinsic PLR suppression
and during aging. However, the mechanisms underlying these observations remain unknown. Therefore, we
propose two specific aims to test the hypothesis that the coincident onset of AD, OA, and skeletal fragility arises
from age-related deregulation of shared cellular mechanisms in neurons and osteocytes, which in turn disrupts
bone/brain crosstalk. Aim 1 will determine the extent to which osteocyte-intrinsic defects compromise bone/brain
crosstalk and cognition; whereas Aim 2 will determine the extent to which ADRD compromises osteocyte and
skeletal function. We continue to take advantage of the TbRIIocy-/- mouse model in the parent grant, which will be
tested for cognitive decline, behavioral changes, and other markers of early and late AD. In parallel, we introduce
new AD mouse models to our studies, applying the skeletal outcomes from the parent grant to the 3xTg AD and
APOE4 AD models to investigate effects of AD on osteocytes, PLR, bone quality, and OA. Throughout, we will
leverage unparalleled bone and brain proteomic profiling to detect evidence of bone/brain crosstalk and to
evaluate pathways common to bone and brain degenerative diseases. Obtained results will prioritize mechanistic
gain and loss of function studies to test the hypothesis that TGFb-dependent PLR suppression and osteocyte
mitochondrial dysfunction play a causal role in the age-related decline in bone quality and joint health, and how
the latter mechanism affects bones in AD models. These studies will reveal if PLR suppression in aging and OA
represents a common cellular mechanism that drives the temporal decline of bone quality and joint health during
AD/ADRD progression, which may identify strategies to coordinately improve skeletal and neurological health.

Public health relevance
NARRATIVE The active role of osteocytes, cells embedded within bone, in maintaining skeletal health is disrupted with aging. Here we test the possibility that the disruption of osteocyte function with age contributes to age-related bone fragility, joint degeneration, and their role in Alzheimer’s disease. Testing this hypothesis will advance our understanding of mechanisms by which cells in the skeleton participate in crosstalk with the brain, which could improve the success of clinical efforts to protect musculoskeletal and cognitive health throughout the lifespan.